ENDOSCOPIC IMAGING W/ OPTICAL COHERENCE TOMOGRAPHY

The experimental technique of interferometric surface monitoring has been used to study the onset of laser ablation. Preliminary data is currently in press (Lasers in Surgery and Medicine, 1994). Recently, more improvements have been made in this technique. The improved technique allows a careful monitoring of laser-induced cavitation phenomenon in water with a temporal resolution of a few nanoseconds. This technique has also been applied to "soft" tissue (meniscus) and it has been shown that cavitation occurs within meniscus. Experiments are currently underway to study this process in more detail to determine the role of cavitation in the initiation of the ablation process.